Reducing Overdose and Suicide Risk in Individuals with OUD and Co-occurring Disorders

PROJECT ABSTRACT
Suicide and overdose deaths are at record levels, and the Emergency Department (ED) is at the forefront of
delivering care to those at the highest risk. Opioid use disorders (OUD) and mental illness are major
contributors to both. In 2017 nearly half of suicide and overdose deaths were linked to opioid use, with the
highest death rates seen in people with both OUD and mental illness. Medications for OUD (MOUD) saves
lives, and substantial research has documented the dose-response relationship between retention in MOUD
care, all-cause mortality, and suicide/overdose. The California Bridge Program (CA Bridge) is the largest ED-
based addiction treatment implementation project in the US; the primary goal is to improve MOUD access and
linkage to outpatient care for patients with OUD. However, data from the first 52 hospitals suggest that over
60% of patients had not filled an outpatient MOUD prescription two weeks after the ED visit; national data
suggest that even when patients start MOUD, many discontinue treatment, putting them at increased risk of
relapse, overdose, and death. Given finite resources, ED providers need evidence-based guidance about
the optimal way to manage patients where there is both between-person heterogeneity (despite being
offered services many patients do not access them) and within-person heterogeneity (even when MOUD is
initiated many patients discontinue treatment), and information about whether patients with a prior history of
either overdose or a co-occurring mental illness should receive a different sequence of interventions. This
combination of between- and within-person heterogeneity, suggests the need for an adaptive intervention
(AI) approach, whereby MOUD service-delivery interventions are adapted based on the patient’s initial
presentation and changing status. We propose a Sequential Multiple Assignment Randomized Trial to inform
the development of an AI that is optimally effective in increasing buprenorphine use for adults presenting to the
ED with an OUD-related event. Our primary outcome is the number of days a prescription for buprenorphine
was filled in the 6 months following the initial ED visit. Our pre-specified secondary outcome is a composite
measure of the time between ED presentation and subsequent overdose or suicide events, including death. To
conduct the study, we leverage a partnership between RAND, UCLA, Stanford and two hospitals that were
early adopters of CA Bridge. ED providers typically provide time-limited care for acute problems in the ED,
forcing an unrealistic and high-stakes hand off during a critical transition point. Testing different service-
delivery interventions and proactively addressing the key nature of this transition, is innovative and puts
forward a new vision of ED care. Our study is aligned with NIDA’s priorities as outlined in NOT-NS-20-005 and
will provide definitive answers to multiple critical questions, necessary for building an optimal AI that has the
potential to increase long-term MOUD use and save lives being lost to overdose, suicide, and untreated OUD.

Public health relevance
PROJECT NARRATIVE Suicide and overdose are at record levels and continue to rise; opioid use disorders (OUD) and mental illness are major contributors to both. Emergency Departments (ED) are a key location in which to engage patients. This study will inform the development of an adaptive intervention that is optimally effective in increasing buprenorphine use for adults presenting to the ED with an OUD-related event.